A Learning Health System Approach to Improve the Effectiveness of Blood Transfusions during Septic Shock

PROJECT SUMMARY/ABSTRACT
Septic shock is a common, often fatal, dysregulated host response to infection that results in acute circulatory
failure. Almost all patients with septic shock either have anemia (i.e., low blood counts) on presentation or
develop anemia during hospitalization and anemia in septic shock is strongly associated with morbidity and
mortality. Almost 60% of patients with septic shock receive autologous red blood cell transfusions to treat
anemia once hemoglobin levels drop below 7.0 g/dL (threshold-based transfusion strategy). However, there is
conflicting guidance and evidence for whether all patients with septic shock and hemoglobin levels <7.0 g/dL
should receive transfusion or whether blood transfusion should be guided by additional clinical criteria beyond
hemoglobin level alone. In a recent study, we found that routine threshold-based transfusion strategies for
patients with sepsis were, on average, associated with harm. In the setting of conflicting guidance and limited
evidence of effectiveness, practice patterns for blood transfusion in septic shock are also unclear. Guided by a
Learning Health System framework that is consistent with the National Heart, Lung, and Blood
Institute's clinical trial and implementation research priorities, this proposal's objective is to improve
the effectiveness of blood transfusions during septic shock. We will (1) benchmark hemoglobin threshold-
based blood transfusion practices in patients with septic shock across United States hospitals using a novel
econometric-based approach, (2) use cutting-edge causal inference techniques to identify blood transfusion
heterogeneity of treatment effect (i.e., identify patients most, and least likely to benefit from blood transfusion),
and (3) pilot the implementation of an evidence-informed transfusion decision aid in the Boston Medical Center
Medical Intensive Care Unit. Through his comprehensive career development plan, interactions with his
excellent mentoring and advisory team, and the excellent training environment of Boston University Chobanian
& Avedisian School of Medicine and Boston Medical Center, Dr. Bosch will achieve training objectives in (1)
econometrics, (2) observational comparative effectiveness and causal inference, (3) mixed methodologies (4)
hybrid implementation-effectiveness clinical trials, and (5) research team leadership that are aligned with core
competencies to train the new generation of Learning Health System researchers. Results from this mentored
proposal will fill large knowledge gaps in septic shock and transfusion medicine, will yield clinically actionable
information regarding the optimal approach to blood transfusion in critically ill patients, and will inform Dr.
Bosch's R01 application for a multicenter, pragmatic Hybrid Type 1 randomized clinical trial studying the
effectiveness of transfusion guided by decision aids.

Public health relevance
PROJECT NARRATIVE Almost 100% of patients with septic shock—the most severe form of sepsis – have concurrent anemia; anemia in septic shock is often treated with blood transfusions when hemoglobin levels drop below 7.0 g/dL, but little is known about the effectiveness of this hemoglobin threshold-based blood transfusion strategy. The goals of this proposed research are to (1) examine practice pattern variation in threshold-based transfusion strategies in patients with septic shock across the United States, (2) identify patients with septic shock who are most, and least likely to benefit from threshold-based blood transfusion, and (3) pilot the implementation of an evidence- informed decision aid to improve and standardize transfusion practices during septic shock using a Learning Health Systems approach. Completion of this mentored career development proposal will be critical in informing septic shock clinical practice, guideline development, and future clinical trials and providing invaluable training in Learning Health System core competencies.